Efficacy of a multi-level intervention designed to promote adherence to WCRF/AICR dietary guidelines for cancer prevention

Abstract
Organizations such as the World Cancer Research Fund/American Institute for Cancer Research
(WCRF/AICR) recommend that adults eat a diet rich in whole grains, vegetables, and fruit; limit consumption of
“fast foods” and other processed foods high in fat, starches, or sugars; and limit consumption of red and
processed meat and sugar sweetened beverages (SSBs). The degree of adherence to these dietary guidelines
predicts cancer incidence and cancer-related mortality. Primary prevention programs that facilitate sustained
adherence to these dietary recommendations are sorely needed. The proposed study will evaluate the efficacy
of a preventive intervention informed by the profound influence the food environment has on eating behavior.
Our team pilot tested the planned approach and intervention delivery with a factorial design, yielding data on
feasibility, acceptability, and effect sizes that informed the optimization of the experimental intervention
components. In the proposed study, index participants (n = 236) will be randomized to either receive nutrition
education (i.e., control group) or the experimental intervention, which is referred to as “Eatwell.” Both
conditions will provide an equal number of group sessions held remotely over a period of 18 months. The
curriculum in both conditions will be mindful of social determinants of health. In the Eatwell condition, grocery
shopping will be the primary intervention target, with the goal of maximizing availability of healthy foods and
limiting availability of unhealthy foods in the home environment. The intervention also will encourage
participants to increase the proportion of meals prepared at home to take advantage of the optimal defaults
present there, and teach strategies to manage temptation when eating away from home. Eatwell coaches will
provide a foundation of nutrition education, teach self-regulation skills, and use innovative methods to enhance
motivation for change (e.g., using a digital platform to monitor and provide feedback on grocery purchases).
Eatwell will employ a multi-level approach, such that each index participant (i.e., the participant who initiates
enrollment) will invite an adult household member to engage in select aspects of the intervention, to increase
support for change in the home food environment. We expect that focusing on the home food environment will
heighten the intervention impact, improving dietary quality and decreasing cancer risk for all members of the
home. Assessments will be completed at months 0, 6, and 18. Dietary intake will be measured with food
recalls, yielding a cancer prevention dietary adherence score as the primary outcome. Intake of fruit and
vegetables and fiber; ultra-processed foods; red meat and processed meat; and SSBs will be examined as
secondary outcomes. The biological impact of the intervention on inflammation will be measured with
interleukin-6 and C-reactive protein. Changes in dietary quality among household members will be evaluated.
Mediators and moderators of intervention effects will be tested. The findings will be relevant not only to the field
of cancer prevention, but to the prevention of other diseases for which dietary quality is important.

Public health relevance
Narrative Risk for cancer can be reduced by consuming adequate fruits, vegetables, and whole grains, and limiting intake of red and processed meats, sugar sweetened beverages, and highly processed foods. This study is designed to test the extent to which a new program can help adults to follow these dietary recommendations for cancer prevention.